Role of inhibitory G protein signaling in regulating beta-cell function and survival in the type 1 diabetic state

PROJECT SUMMARY The International Diabetes Federation estimates the global burden of diabetes to have skyrocketed to over 387 million people with healthcare costs reaching over $612 billion in the United States alone. Diabetes management for these individuals, particularly Type I Diabetic patients, is extremely rigorous and does not provide an efficient means of disease maintenance. Current standard of care for patients with Type I Diabetes is treatment with exogenous insulin, a measure, which simply put, allows patients to live normally, but does not inherently solve any of the underlying pathologies associated with the disease. Additionally, there are very few Type I Diabetes adjuvant therapeutics, none of which are known to improve β-cell health and function. We have a growing body of evidence that suggests that this protein, specifically the alpha subunit (Gαz) plays a notable role in mediating pathways regulating multiple β-cell pathologies associated with Type I Diabetes. Therefore, our long-term goal is to fully elucidate the signaling mechanism by which Gαz acts in both normal and diabetic β-cells, determining the steps that become dysfunctional in the diabetic state, and ultimately modulating these steps for preventative and therapeutic purposes. The overall objective of this work, which is the next logical step in pursuit of our goal, is to characterize the role of β-cell Gαz on the molecular and cellular signaling pathways responsible for its impact on diabetes pathophysiology. Our central hypothesis is that activated β-cell Gαz negatively modulates specific intracellular and autocrine/paracrine signaling pathways critical for β-cell compensation, ultimately leading to β-cell dysfunction and loss of β-cell mass resulting in diabetes pathogenesis. We will test our central hypothesis and, thereby, accomplish the objective of this application, by pursuing the following two specific aims: (1) Determine the role of β-cell Gαz on β-cell function in the Type I Diabetic condition and (2) Elucidate the effect of β-cell Gαz on signaling pathways that mediate β-cell survival following insulitis. With the completion of these aims, we anticipate a much more complete understanding of the role of Gαz in both healthy and diabetic β-cells. Such results are anticipated to have an important positive outcome on the diabetes field, as Gαz is a unique player in the integrated signaling pathways that mediate β-cell function and survival, providing a new target for developing therapeutics for the prevention and treatment of Type I diabetes.

Public health relevance
PROJECT NARRATIVE Diabetes is a costly and complex chronic illness and a serious public health problem, responsible for a host of complications that significantly decrease healthy lifespan. The underlying issue in diabetes is the failure of the pancreas cells to release enough of the hormone, insulin, into the blood stream to properly control blood sugar levels. The aims of this proposal are to characterize the role of the inhibitory G protein, Gz, in the regulation of pathways which alter insulin secretion and beta-cell survival, ultimately resulting in novel pharmaceutical interventions which improve outcomes for diabetic patients.